Platelet Expression of FcgammaRIIa and Arterial Hemodynamics to Predict Recurrent Stroke in Intracranial Atherosclerosis

PROJECT SUMMARY/ABSTRACT
The overall goal of this proposal is to determine the potentially pivotal and interactive roles of individual
platelet expression of FcγRIIa [SA-1] and wall shear stress (WSS) calculated from patient-specific CT
angiography (CTA) computational fluid dynamics (CFD) [SA-2] to explain recurrent ischemia after minor
stroke or TIA due to ICAD. A precision model is developed [SA-3] to quantify risk of recurrent ischemic injury,
accounting for FcγRIIa, WSS, anti-platelet therapies and platelet reactivity, across a diverse population of
stroke and TIA patients with ICAD. Our central hypothesis is that high FcγRIIa plus high shear force pose
individual and synergistic risk of stroke recurrence, providing a rational basis for the precision medicine of
stroke prevention in ICAD. Our preliminary data reveal that greater platelet FcγRIIa expression identifies
patients at greater risk of recurrent cardiovascular events including stroke and that high WSS on CTA CFD
predicts recurrent stroke due to ICAD at 1 year. Our three independent specific aims leverage an established
research infrastructure and ICAD network of 6 geographically distinct enrolling sites with race-ethnic diverse
populations and a longstanding history of productive collaboration to recruit 250 participants with acute
cerebral ischemia within 72 hours from symptom onset. The multicenter, observational study will enroll stroke
or TIA patients due to 50-99% ICAD diagnosed on routinely acquired CTA and obtain brain MRI and blood
sampling for FcγRIIa and platelet assays within 72 hours and again at 1 year after onset. Clinical outcomes will
be ascertained at 90 days and at 1 year, with co-registration of serial MRI to quantify interval silent and
symptomatic ischemic injury. The Platelet Biology Core at University of Vermont will quantify platelet FcγRIIa
expression. The Neurovascular Imaging Research Core at UCLA will conduct central imaging analyses,
including CTA CFD quantification of WSS, serial MRI co-registration and imaging adjudication of eligibility
and interval endpoints. The Statistical Core will coordinate data management from 6 enrolling sites and the
core facilities, conducting predictive statistics, stratification of key biological variables and novel application of
clustering analytic strategies to maximally inform a precision model of ICAD stroke risk at 1 year. This timely
culmination of synergistic work on shear stress-induced platelet activation in ICAD leverages our robust
preliminary data on FcγRIIa, CTA CFD of WSS and precision medicine analytics in stroke, layered on a
successful track record of multicenter, observational studies of the most common cause of recurrent stroke.
Measurement of individual differences in FcγRIIa and shear stress induced by heterogenous arterial stenoses
inform a logical precision medicine strategy to avert stroke. This novel strategy of using diagnostic data easily
acquired shortly after stroke or TIA due to ICAD has clear implications for clinical translation via precision
medicine enabling individualized stroke treatment, focused on mechanisms of platelet pathophysiology while
addressing clinical events and silent, insidious brain damage due to recurrent ischemia distal to the plaque.

Public health relevance
PROJECT NARRATIVE/ RELEVANCE TO PUBLIC HEALTH STATEMENT This multicenter study of Platelet Expression of FcγRIIa and Arterial Hemodynamics to Predict Recurrent Stroke in Intracranial Atherosclerosis advances recent data on blood flow changes in brain arteries that cause repeated injury and disability. New approaches to blood samples and imaging of mechanical forces around narrowed arteries are used to predict new strokes and silent brain damage over the course of 1 year. The research has direct implications for enhancing precision medicine of stroke, targeting the devastating consequences of the most common cause of stroke and leading cause of disability with vast disparities around the world.